The Role of Habenular Hyperactivity in the Action of Tianeptine, a Novel Treatment for Neuropathic Pain

Project Summary/Abstract
Neuropathic pain (NP) is defined as chronic pain following injury or disease in the somatosensory
nervous system resulting in pain and affective symptoms. The primary treatments are monoamine targeting
antidepressants, which roughly half of patients do not respond to. An atypical antidepressant called tianeptine
(TIA) was discovered by our lab to be an MOR agonist, but differs from other opioids by lacking euphoric
quality, metabolizing rapidly out of the body, and not showing tolerance/withdrawal effects all at clinical doses.
Preliminary data indicates that TIA reduces allodynia from NP, without rapid tolerance as observed in
morphine. How and where TIA is acting to relieve these symptoms is unclear. One candidate region is the
habenula (Hb), which is dysregulated in chronic pain, and has inhibitory outputs to several monoamine
regulating regions. Typically, neurons in the Hb fire in response to aversive stimuli, inhibiting those
downstream reward pathways. Under chronic pain, the region becomes hyperactive. One option for how this
happens relates to the habenula having the densest MOR expressing in the brain. MORs are typically
inhibitory, and activated by the release of endogenous opioids. However, during chronic pain this system
becomes dysregulated and, in many regions, MORs decrease in expression or availability. I hypothesize that
pathological hyperactivity in the Hb, which is associated with an increase in allodynia and anhedonia, is at least
partially due to a decrease in MOR expression or availability under conditions of chronic pain, and that chronic
TIA administration will normalize activity in the region, correlating with decreased NP behaviors. In order to
address this, I will use the spared nerve injury model (SNI) of NP, which induces both painful and affective
symptoms, including allodynia and anhedonia. In Aim 1, I will test the hypothesis that habenula hyperactivity is
related to changes in MOR activity, and that tianeptine normalizes habenular activity in NP. In 1.A, I will
perform fiber photometry in SNI and sham control male and female MOR-Cre mice. I will measure calcium
activity in both global and MOR expressing cells in the Hb, during measures of allodynia and anhedonia. In
1.B, I will chronically treat animals with TIA, and observe if this results in reversal of neural and/or behavioral
disparities between SNI and control mice. In Aim 2, I will examine the molecular and transcriptional changes
caused by NP and following chronic TIA treatment by comparing habenular tissue from sham/vehicle,
SNI/vehicle, sham/TIA, and SNI/TIA mice. In 2.A, I will use a protein ligation assay to examine changes in
MOR expression with regional detail, and in 2.B, I will analyze scRNAseq data for both broad transcriptional
changes induced by pain and tianeptine, how co-expression patterns change between conditions. This will
allow me to observe if the ratio of MOR co-expression shifts, as it did in preliminary re-analysis of published
data looking at the habenula following acute unavoidable shock. To date, no studies have looked at habenular
MORs during neuropathic pain.

Public health relevance
Project Narrative Neuropathic pain is a chronic disorder characterized by increased pain sensitivity and depressive symptoms, as well as hyperactivity in the habenula, a brain region with inhibitory projections to monoaminergic reward pathways, and the densest site of mu-opioid receptor (MOR) expression in the brain. Tianeptine, an atypical antidepressant recently discovered to be an MOR agonist, shows promise as a novel treatment for NP, but it is unclear how it alleviates pain and affective symptoms. As MORs often become unavailable during chronic pain, and the habenula is both dense in these inhibitory GPCRs and hyperactive in chronic pain, this project will investigate the possibility that MOR dysregulation underlies NP symptoms and tianeptine functions by inhibiting hyperactivity in the habenula.